Roles and regulation of tissue resident CD8 T cells during a persistent viral infection

SUMMARY
Sustained viral infections are characterized by a long-term equilibrium between the pathogen and the immune
system that is enabled by adaptations of immune cells that attenuate selected functions. This equilibrium
keeps the pathogen in check while minimizing immunopathology. Thus, studying the mechanisms that naturally
evolved to allow adaptation of immune cells during sustained infections has great potential to uncover
fundamental aspects of immune regulation that could be exploited to treat both infectious and non-infectious
diseases.
The above concept is illustrated by the discovery of exhausted CD8 T cells (TEX) as a distinct
differentiation fate that is maintained by a stem-like progenitor subset (TEX-STEM), which is mostly restricted to
lymphoid tissues and gives rise to all other TEX populations. Notably, these findings were originally made in
mice chronically infected with lymphocytic choriomeningitis virus (LCMV) and then extended to many human
viral infections, cancer, and autoimmune diseases. Following the same steps, we and others have recently
taken advantage of the LCMV mouse model to study immune adaptations in the gastrointestinal (GI) tract. We
revealed that the persistent LCMV isolate, Clone 13 (Cl13), productively replicates in the intestinal lamina
propria (LPL), but not in the intestinal epithelium, and that this infection is associated with enhanced intestinal
permeability to small molecules and increased susceptibility to chemically and bacterially induced colitis. We
also uncovered that, during chronic LCMV infection, Type I interferons (IFN-I) promote tissue-associated virus-
specific CD8 T cells (hereafter refer as T resident cells TRC) while preventing the emergence of TEX-STEM cells in
intestinal tissues. Importantly, both IFN-I and CD8 T cells were essential for the hyper-permeability and
enhanced colitis observed after LCMV Cl13 infection.
Our overall goal is to leverage our previous studies to uncover the basic biology of tissue-resident CD8
T cell responses in the context of a sustained viral infection and determine if and how these responses
contribute to the development of pathology and viral control in intestinal compartments. To accomplish this
goal, we plan to (1) Evaluate the role of TRC in intestinal hyper-permeability and colitis during a sustained viral
infection, (2) Investigate how IFN-I regulates intestinal TRC during sustained vs. acute viral infection, and (3)
Identify the source(s) of IFN-I that regulate intestinal TRC during sustained vs. acute viral infection.
Overall, our studies will use a combination of classic immunological techniques and cutting-edge
technologies to characterize how TRC develop and are maintained during a long-term infection, as well as
define the potential consequences of this response on tissue homeostasis and viral control. This work will
significantly improve our understanding of tissue-specific T cell responses and their roles in protection and
pathogenesis and open the door to directed therapeutics aimed at leveraging or tempering the power of tissue-
resident responses to improve human health.

Public health relevance
NARRATIVE CD8 T cells associated with tissues exert important roles in pathogen control and have also been linked to immunopathology and disease. This proposal takes advantage of the expertise of two laboratories to investigate the cellular and molecular pathways leading to the generation and functions of intestinal associated CD8 T cell populations in chronic vs. acute viral infections, and evaluate the downstream consequences for viral control, intestinal hyper-permeability and colitis. Our results are expected to illuminate strategies to engineer “tissue-tailored” T cell responses, regulating their trafficking, retention, and/or function within the intestines, and perhaps other tissues, to improve the health of virally infected individuals.